GROWTH HORMONE /CHILDREN /ACUTE LYMPHOBLASTIC LEUKEMIA

The specific aims of the study are to determine 1) if St. Jude total therapy protocols X and XI are associated with compromised growth and adult short stature, 2) if the height prediction formula derived from the data of children treated with 24 Gy cranial irradiation accurately predicts height outcome and 3) if patients predicted to have short stature have growth hormone deficiency.